HIV and Malignancy Scientific Working Group

PROJECT SUMMARY/ABSTRACT: HIV and Malignancy Scientific Working Group
The overall goal of the HU CFAR HIV & Malignancy Scientific Working Group (SWG) is to address this growing
burden of malignancies among PLWH by 1) engaging community partners, clinicians, and scientists; 2)
facilitating clinical and specimen data synthesis and interpretation; and 3) supporting investigators, especially
Early Career Investigators (ECIs). Through these activities, we will accelerate the discovery of mechanisms
and interventions to prevent and treat cancers among PLWH. A key theme through these three aims is
catalyzing translational research and identifying priorities at each translational stage and guide the process to
ultimately have impact on individual and population-level health. The HU CFAR is uniquely positioned to
leverage experts, clinical and basic science resources, and data and specimens to address scientific questions
about HIV and malignancies. To continue to provide high-impact, rigorous training and mentorship for ECIs, we
propose the following Specific Aims: 1) Support high-priority, cross-disciplinary HIV research activities at
Harvard University and with international colleagues through Developmental and Mentoring Core Scholar
Awards. 2) Foster leadership development at Harvard and affiliated international sites through a mentoring
program for ECIs and structured training opportunities for their mentors.3) Grow and diversify the HU CFAR
community through formal outreach and orientation activities, linkage with Scientific Working Groups, and
funding opportunities that support diversity, equity, and inclusion.